Defining pro-metastatic and endothelial-regulatory roles for LIN28B in hepatocellular carcinoma

PROJECT SUMMARY
Hepatocellular carcinoma (HCC) is a lethal solid tumor that is highly dependent on recruitment of new blood
vessels and has no common genomic targets. As for most solid tumors, metastasis causes a disproportionate
degree of morbidity and mortality. LIN28B – an RNA-binding protein expressed in tumors and in developing
tissues – is essential for HCC development and elevated LIN28B expression in HCC correlates with an increased
risk of death. We recently identified LIN28B as a novel driver of pancreatic cancer metastasis and propose in
Aim 1 to use an integrated series of molecular, cellular, and animal experiments to determine if HCC metastasis
is driven by LIN28B. In Aim 2, I propose to couple robust co-culture (HCC cell and endothelial cell) in vitro and
in vivo models to define how LIN28B expression in HCC cells modulates its effect on endothelial cells, which in
turn stimulate the HCC metastatic phenotype. In Aim 3, I will utilize our expertise in novel circulating tumor cell
purification/analysis technologies and computational analysis of conventional and novel tissue staining
technologies to characterize the metastasis-driving and endothelial regulatory roles of LIN28B using primary
human circulating tumor cell and tumor tissue specimens. Collectively, this work will provide functional rationale
for the development of new therapies targeting the LIN28B pathway and linked vascular-regulatory pathways in
HCC and for the development of novel matched biomarkers. The applicant, Dr. Joseph Franses, is an oncologist
at the University of Chicago Cancer Center. He will spend 75% of his time performing translational research and
25% in clinical practice caring for patients with cancer. He has outlined a five-year career development plan to
meet his goal of becoming an independent investigator in translational research. Dr. Franses has assembled an
Advisory Committee of internationally recognized experts to provide scientific and career mentorship. He has
established collaborations with experts in cancer genomics, molecular biology, tumor animal modeling, and
computational biology to provide experimental advice and specific training in the field. Dr. Franses will conduct
this research and leverage the exceptional research and teaching environment at the University of Chicago
Cancer Center. The University of Chicago harbors an outstanding research community and has a long track
record for successful mentorship of independent physician-scientists. This will be an ideal environment for
successful completion of these experiments and the realization of Dr. Franses’ career goal of becoming an
independent physician-scientist dedicated to improving the care of patients with gastrointestinal cancers.

Public health relevance
PROJECT NARRATIVE LIN28B is a pleiotropic RNA-binding oncofetal protein that correlates with poor prognosis in hepatocellular carcinoma (HCC). This proposal seeks to understand how LIN28B contributes directly to the metastatic phenotype of HCC cells and how it contributes to the angiogenic and endothelial modulatory phenotype of HCC cells using a combination of cell, animal, and human specimen studies. I anticipate that these results will provide rationale and targets for novel drug and biomarker development for HCC.